Mechanisms of Neuronal Excitability and Pain in Fabry Disease

Project Summary
Fabry disease is the most common lysosomal storage disorder, arising from mutations in the X-linked gene Gla
and subsequent accumulation of intracellular globotriaosylceramide (Gb3) and lyso-Gb3. Patients with Fabry
disease frequently develop a painful small fiber neuropathy, which is exacerbated following heat-induced pain
crises. Little is known, however, about the mechanisms contributing to pain in Fabry disease, and even less is
known about the mechanisms of pain exacerbation during pain crises in these patients. This is in part due to
the evidence that mouse Fabry models poorly recapitulate the pain in patients with Fabry disease. In rodent
models of painful neuropathy, sensory neurons in the dorsal root ganglion often exhibit spontaneous activity
and increased excitability. Our rat model of Fabry disease exhibits sensitization of mechanical pain behaviors,
spontaneous activity, and both mechanical- and current-evoked excitability of dorsal root ganglion neurons. We
have recently demonstrated a p11-dependent glial-neuron signaling axis in Fabry disease that results in
increased current-evoked excitability and voltage-gated sodium (NaV) channel current density. This suggests
NaV channels may contribute to sensory neuronal hyperexcitability and pain behaviors in Fabry disease;
however, it is not clear which NaV channels are hyper functional in Fabry disease, nor is it clear whether
neuronal-intrinsic mechanisms also contribute to their dysregulation. Moreover, it is unknown whether heat
contributes to increased neuronal excitability in Fabry disease. In the aims outlined in this proposal, I will use
voltage-clamp patch electrophysiology, mechanical- and current-evoked patch electrophysiology, and a battery
of reflexive and non-reflexive behavioral measures of pain to identify molecular mechanisms contributing to
neuronal and behavioral sensitization in Fabry disease at steady state (Aim 1) and following heat-induced pain
crises (Aim 2). In Aim 1, I will identify which NaV channels exhibit altered biophysics in Fabry disease sensory
neurons at steady-state (Aim 1A) and determine whether these channels are similarly dysregulated by Gb3
and lyso-Gb3 (Aim 1B). In Aim 2, I will determine whether Fabry rats are sensitized to reflexive and non-
reflexive behavioral measures of pain following heat treatment (Aim 2A). Further studies will determine whether
heat-treatment potentiates mechanically evoked (Aim 2B) and current-evoked (Aim 2C) excitability in dorsal
root ganglia neurons from Fabry rats. These studies will ultimately identify which voltage-gated sodium
channels underpin increased neuronal excitability at steady state and whether further increased neuronal
excitability contributes to heat-evoked pain crises in Fabry disease. Overall, the proposed aims will definitively
determine mechanisms contributing to excitability and pain in Fabry disease, potentially revealing therapeutic
targets to reduce pain and improve quality of life in patients afflicted by Fabry disease.

Public health relevance
Project Narrative Patients with Fabry disease experience debilitating chronic pain in addition to episodic pain evoked by heat or exercise, yet there is a dearth of literature examining the mechanisms that contribute to pain in these patients. Sensory neurons in Fabry disease exhibit increased excitability and spontaneous activity. This proposal investigates the regulation of voltage-gated sodium channels contributing to neuronal excitability in Fabry disease and determines the role of elevated neuronal excitability in heat-evoked pian crises in Fabry disease.